Improving Research Resources at the TNPRC to Support COVID-19 Research

PROJECT SUMMARY/ABSTRACT The Tulane National Primate Research Center (TNPRC) is one of seven National Primate Research Centers (NPRCs) sponsored by the National Institutes of Health. The Center is dedicated to providing the infrastructure and support for basic and applied research efforts to advance scientific knowledge and improve human and animal health and wellbeing. Resources provided to core and affiliate scientists include well-characterized nonhuman primates and state-of-the-art research instrumentation. The TNPRC has one of the largest Indian-origin rhesus monkey breeding colonies in the United States. Over the past five years, these colonies produced between 200-900 infants a year and provided close to 2,000 animals for biomedical research programs. Currently, there is high demand for specific pathogen free (SPF) macaques on a national level, which requires continued availability of these resources. The TNPRC P51 base grant (P51 OD011104) provides funds to support and maintain this colony, while two U42 grants and program income derived from animal sales supply additional funds. Ongoing support for moderate expansion of the SPF colony will continue to come from sources other than the TNPRC P51 base grant and U42 grants, including program income from the sale of animals, construction grants, and supplements. A variety of core laboratories support TNPRC research and animal care activities, including a newly established High Containment Research Performance Core. This core includes both BSL-2 and BSL-3 spaces and operates under a quality assurance model to enhance rigor and reproducibility. These laboratories are equipped with high- end instrumentation used to generate high quality data from nonhuman primate research. Additional laboratory equipment is needed to support a rapidly expanding and critically needed coronavirus research program. This supplement to the P51 base grant will be used to add one new outdoor housing enclosure, enable use of another existing enclosure on the breeding colony campus, and to provide funds for purchase of research instrumentation. The proposed breeding colony enclosures will be used to house SPF animals and have been designed to maximize capacity and flexibility for the available funding and to provide novel and proven environmental enhancement components. The addition of nonhuman primate housing and equipment resources falls within the goals of the parent award. The benefits realized from these improvements will assist our efforts to enhance our capability to support core and affiliate scientists? COVID-19 research programs.

Public health relevance
PROJECT NARRATIVE The Tulane National Primate Research Center (TNPRC) provides resources to core and affiliate scientists to support biomedical research using nonhuman primates, including specific pathogen free (SPF) rhesus macaques and state-of-the-art diagnostic instrumentation used to generate high-quality data. This supplement to the TNPRC P51 base grant provides for an infrastructure expansion to add modernized housing to support our SPF macaque breeding colony and the purchase of equipment used to support COVID-19 research. These improvements will help to ensure the expansion of a unique, well-characterized animal resource and promote cutting-edge research technology.